Deficient Belief Updating as a Convergent Computational Mechanism of Psychosis

The psychotic syndrome of schizophrenia, comprising hallucinations and delusions, remains one of the most
devastating and costly medical conditions in the US and worldwide. Despite progress in the understanding of its
neurobiology, a unifying mechanism remains elusive. Elucidating such mechanism would be a major advance in
medicine, as it would provide a scientific explanation to symptoms that have long been considered synonymous with
irrationality. This would contribute to de-­stigmatization of mental illness. It would also potentially lead to important
public health benefits by identifying novel targets that could enable new treatments for a substantial proportion of
patients (~1/3) who do not respond to or tolerate current treatments. Previous work has separately studied the
substrates of hallucinations (false percepts without corresponding stimuli) and of delusions (false ideas that are
maintained with high conviction despite contradictory evidence). However, recent theories of the brain suggest that
perception and ideation are part of a unitary process, whereby the brain generates and updates internal predictive
models of the external world, that can explain both our idiosyncratic perceptual experiences and how we reach certain
conclusions or ideas based on these experiences. Extensions of these ‘Bayesian’ theories have been proposed to
explain pathological abnormalities in perception (e.g., hallucinations) and ideation (e.g., delusions) in psychosis as
deriving from a common deficit. We suggest that this common deficit is a dopamine-­related deficit in updating of
beliefs (defined via computational modeling) given excessive reliance of prior beliefs relative to new sensory evidence.
We posit that this deficit can occur at two different levels of a hierarchy: a lower level (in sensory cortex) abnormalities
in which would cause hallucinations, and a higher level (higher-­order prefrontal and parietal cortices supporting
inference) abnormalities in which would cause delusions. We propose a converging approach to directly test this novel
model it by leveraging cutting-­edge tools in computational neuroscience applied to functional neuroimaging (fMRI) and
behavioral tools designed to dissect hierarchical belief updating. Specifically, we hypothesize a behavioral and neural
double dissociation whereby deficits in the former will be specifically associated with severity of hallucinations while
deficits in the latter will be specifically associated with severity of delusions in unmedicated patients with
schizophrenia. By anchoring our model on the well-­established dopamine dysfunction in psychosis, we will explain
how increased dopamine in the midbrain (specifically, in the nigrostriatal pathway, here measured via a novel, high-­
resolution imaging technique known as neuromelanin-­sensitive MRI) alters common neural computations leading to
psychotic symptoms (i.e., how it results in deficient belief updating at low and high levels, leading to hallucinations and
delusions, respectively). Finally, we will define neural targets to set up future work developing novel neuromodulation
approaches aimed at normalizing belief updating deficits downstream from dopamine abnormalities. Thus, we will
establish novel downstream mechanisms of psychosis that can be further dissected in preclinical work and can be
directly targeted in humans depending on individuals’ symptom profiles.

Public health relevance
PROJECT NARRATIVE The psychotic syndrome of schizophrenia (including hallucinations and delusions) remains among the most incapacitating and burdensome conditions worldwide, particularly for a substantial proportion of patients (~1/3) whose symptoms do not improve sufficiently with currently available treatments, and is perhaps the most puzzling state in clinical neuroscience. By leveraging new computational, statistical, imaging, and behavioral tools, this project aims to establish a novel model that integrats current clinical and neurobiological knowledge into a holistic model of psychosis explaining its common cognitive mechanism as well as symptom-specific pathways. This will advance our understanding of psychosis by delineating core neural processes downstream from dopamine abnormalities that are directly linked to specific symptoms and that can be targeted via novel patient- tailored feedback- based treatments.